Mechanism-inspired Strategies to Prevent Pathogenic Late Na Current in Cardiac Arrhythmias

PROJECT SUMMARY
PI: Manu Ben-Johny, Ph.D.
NaV1.5 channels are fundamentally involved in the normal function and pathophysiology of the heart. NaV1.5
dysfunction is linked to a variety of life-threatening cardiac diseases, including congenital and acquired cardiac
arrhythmias, cardiomyopathies, and heart failure. An emerging commonality for these pathologies is increased
late Na current, that results in sustained Na influx during the plateau phase of the cardiac action potential.
Understanding mechanisms that regulate late Na current is pivotal to understanding NaV1.5 dysfunction in
cardiac pathophysiology and for developing long-sought pharmacology. Our recent studies and preliminary data
suggest that late Na current is powerfully tuned by a Na channel modulator named fibroblast growth factor
homologous factor (FHF) that is endogenous to cardiomyocytes. Yet, how FHF accomplishes this important
mode of NaV1.5 regulation and its relevance to disease pathogenic mechanisms is not fully determined. In this
collaborative project, we seek (1) to dissect the molecular mechanism of FHF regulation of late Na current, and
(2) to identify the physiological and pathophysiological relevance of this modulatory scheme. Armed with in depth
mechanistic insights, we seek to engineer novel peptide-based inhibitors of late Na current. In particular, as FHF
undergoes extensive alternative-splicing, we evaluate isoform-specificity of late Na current regulation using a
novel FRET assay and through extensive single-channel analysis. To probe the physiological impact of FHF
regulation of late Na current, we virally manipulate FHF levels in cardiomyocytes differentiated from long-QT and
mixed-syndrome patient-derived induced pluripotent stem cells as well as transgenic mouse ventricular
myocytes. In so doing, this proposal promises new biophysical and physiological insights into modulation of
cardiac NaV1.5 and inform upon mechanisms underlying variable clinical manifestations of Na channelopathies.

Public health relevance
PROJECT NARRATIVE PI: Manu Ben-Johny, PhD Increased late Na current is a common pathophysiological mechanism for many cardiac ailments including congenital long QT syndrome and heart failure. In this collaborative project, we dissect the physiological role and molecular mechanisms of cardiac Na channel modulation by fibroblast growth factor homologous factors (FHF) in inhibiting late Na current in cultured adult ventricular myocytes and in induced pluripotent stem cell derived cardiomyocytes. We leverage in depth mechanisms to develop a novel peptide inhibitor of late Na current.